CHARACTERIZING AND IMPROVING HUMANIZED IMMUNE SYSTEM MOUSE MODELS (IMM-HIS)

The proposal from the University of North Carolina at Chapel Hill focuses on constructing human immune system mice using neonatal tissue and conducting a detailed immunological analysis of the optimized mouse model. Studies will be done to evaluate the model’s suitability for the study of Epstein Barr virus (EBV) and other infectious diseases.